SERVICE TO GENETIC EPIDEMIOLOGISTS AND USERS OF SAGE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. We continually improve the S.A.G.E. software package and answer questions from users. These questions cover various aspects of S.A.G.E., from how to install and run the programs to finding mistakes that users make in generating data files or setting up analyses, to interpreting the program output. S.A.G.E. programs are provided to users through a user-friendly website, from which individuals may download programs and user documentation. The site also provides information on scheduled short courss and other topics relevant to the software.